Age-related deficits in episodic memory for the content and structure of naturalistic events

PROJECT SUMMARY/ABSTRACT
The exact process of episodic memory loss in aging and Alzheimer’s disease (AD) is not understood. The long-
term goal is to refine our understanding of this process, and its links to pathology in the brain. Critically, our
current ways of assessing memory decline are sufficient to detect frank dementia, but are largely insufficient to
identify those at risk before significant pathology has already accumulated. In part, this lack of sensitivity stems
from the fact that laboratory tests use simplistic, arbitrary stimuli that do not reflect the complexity of the real
world. That is, existing cognitive evaluations are limited due to a failure to capture a central feature of human
memories: they are not unitary, but rather feature representations of specific content in a structured fashion.
These components of memories rely on different brain networks. The objective of this proposal is to determine
the way aging distinctly affects the content (Aim 1) and structure (Aim 2) of memory representations, and how
this relates to dysfunction in different brain networks based on their susceptibility to AD pathology (via plasma
biomarker status, Aim 3). The central hypothesis is that aging will be associated with distinct profiles of memory
deficits for event content and structure, linked to unique brain networks. The rationale underlying this proposal
is that completion of the project will identify two distinct cognitive and neural targets for characterizing, clinically
assessing, and eventually treating AD in at-risk older adults. Our specific aims will test the following hypotheses:
(Aim 1) Aging disproportionately affects memory for local perceptual information, such as people and objects,
which will coincide with dysfunction in an anterior-temporal brain network. (Aim 2) Older adults will show a shift
in brain networks involved in representing event memories and poor differentiation between events compared to
younger adults, leading to a bias toward remembering information at a gist-level and a susceptibility to confusion.
(Aim 3) Plasma biomarkers will predict the extent of age-related dysfunction in memory networks. Specifically,
tau burden will relate to anterior-temporal network dysfunction and memory loss for local perceptual content in
memories, whereas amyloid burden will relate to dysfunction in a posterior-medial brain network and more
widespread memory deficits related to context and structure. This work uses an innovative combination of novel
behavioral testing techniques, as well as cutting-edge brain imaging and plasma proteomic tools. The proposed
research makes a significant contribution, because it will provide foundational evidence that memory loss is not
a monolith, but rather a nuanced process with different components that are uniquely vulnerable to the presence
of pathological biomarkers in AD. Results of this project will have a positive impact on basic research in memory
and aging in that they will provide important evidence for the way the human brain supports the content and
structure of memories, and how this changes across the lifespan. Moreover, this work will inform future clinical
investigations and interventions by refining their targets for understanding and treating specific memory deficits.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cognitive decline in aging and Alzheimer’s disease poses a significant global threat, and understanding the nature of memory decline will refine our diagnostic, clinical, and treatment approaches. These studies employ cutting-edge cognitive neuroscience tools and analytic approaches to answer fundamental questions about how aging lead to the loss of memory content and structure, and will link these factors to Alzheimer’s-related pathology in human brain networks. This work is central to part of NIH’s mission of developing research that will deepen our understanding of aging and vulnerability to Alzheimer’s disease, providing tools for modern clinical assessments and interventions.